Identifying Regulators of Degeneration due to Defective Mitochondrial DNA

Program Director/Principal Investigator (Last, First, Middle): Guo, Ming
Project Summary/Abstract
Neurodegenerative disorders affect 50% of the population over the age of 85. The
strongest risk factor for most neurodegenerative disorders including Alzheimer’s
disease is aging. Accumulation of mitochondrial DNA (mtDNA) mutations leads to
cellular dysfunction, contributes to human aging and can be observed in age-related
diseases such as Alzheimer’s disease, Parkinson’s disease and sarcopenia. Strategies
that reduce the mtDNA deleterious mutation load and improve mtDNA quality control
are likely to reduce the age-related pathologies of neurodegenerative diseases. We
have generated unique transgenic tools in living Drosophila melanogaster post-mitotic
tissues that contain engineered mixed mtDNA deletion mutations (deleterious
heteroplasmy models). We aim to use these systems and system biology approaches to
identify genes and compounds that lead to suppression or enhancement of the
mitochondrial DNA quality control.
OMB No. 0925-0001/0002 (Rev. 03/16 Approved Through 10/31/2018) Page Continuation Format Page

Public health relevance
Public Health Relevance Neurodegenerative diseases affect up to 50% of the population over the age of 85, creating an enormous public health challenge. Mitochondrial dysfunction and accumulation of mtDNA mutations play an important role in aging and neurodegeneration including Alzheimer’s disease and Parkinson’s disease. We aim to fill a knowledge gap – to identify molecular mechanisms that safeguard mitochondrial DNA quality and protect age- dependent neurodegeneration, the identification of which will allow us to develop effective drug targets for delaying aging and age-dependent cellular dysfunction in neurons.